Advanced Immunoassay System for Oregon Veterinary Diagnostic Laboratory

Project Summary/Abstract An advanced immunoassay system is an essential piece of equipment for clinical pathology laboratories to assess the function and response to injury of various disease conditions but especially hormonal changes and cardiac (heart) conditions. Many food contaminants/misformulations, toxins, microbial agents, cancer and other conditions affect hormone levels and damage the heart These can trigger biochemical changes measured by an immunoassay system. The Oregon Veterinary Diagnostic laboratory (OVDL) has an Immulite system that is now 14 years old, lived its functional life expectancy, breaks down routinely, and is no longer eligible for a service contract and therefore needs to be replaced. The OVDL receives a widely varied diagnostic caseload from domestic animals as well as wildlife, aquatic and marine species of the Pacific Northwest. The OVDL services are vital to a variety of clients and to public health, both of which are key to Vet LIRN’s mission. An advanced and reliable immunoassay system is necessary for the OVDL to be fully operational for Vet LIRN projects and investigations.

Public health relevance
Project Narrative An advanced immunoassay system is needed for detection/measurement of alterations in levels of hormones related to reproductive endocrine function, the thyroid, pancreas, and growth hormones as well as markers of cardiac injury all of which can be elicited by food contaminants/misformulations, toxins, microbial agents, cancer and other conditions. Analytes are measured in serum and results give clinicians, diagnosticians, owners and others insight to the degree and type of organ injury. An immunoassay system can measure progesterone, testosterone, estradiol, follicular stimulating hormone (FSH), human chorionic gonadotropic hormone (hCG), luetinizing hormone (LH), prolactin, insulin, c-peptide, microalbumin, thyroid stimulating hormone (TSH), thyroglobulin, free and total T3 and T4, cortisol, adrenocorticotropic hormone (ACTH), growth hormone, troponin I, myoglobin, CKMB, C-reactive protein (CRP). Changes in these can point to general injury in some cases or towards a more precise category or type of injury. Detection of such injuries is integral to the mission of the Vet LIRN program (e.g., food contaminant/misformulation, toxin injury, microbial infection and other conditions)and may aid in identification of a contaminant or other condition. The OVDL’s current immunoassay system needs to be replaced as it is over 14 years old, breaks down routinely and a service contract can no longer be obtained. An advanced immunoassay system will enhance OVDL preparedness for Vet LIRN projects and investigations.